The 14th International Conference on Health Policy Statistics (ICHPS) 2023

International Conference on Health Policy Statistics (ICHPS) 2023
Project Summary
The 14th International Conference on Health Policy Statistics (ICHPS) 2023, hosted by
the American Statistical Association (ASA) and its Section on Health Policy Statistics (HPSS),
will provide a unique forum for the dissemination of statistical methods and data science tools
relevant to contemporary health data and policy research. ICHPS 2023 will engage a host of
stakeholders and bring a variety of perspectives and novel approaches to the salient health
policy issues of today. The timely theme of ICHPS 2023 is “Upgrading the Pipeline from
Health Data to Health Policy,” shining a spotlight on the interconnected nature of health data
and quantitative methods in informing health and policy decision-making. The 14th ICHPS will be
held January 9-11, 2023 at Embassy Suites in Scottsdale, Arizona. Details for the 13th ICHPS
are available online at https://ww2.amstat.org/meetings/ichps/2020/. Participation has continued
to increase, from 246 attendees at the 11th ICHPS in 2015 to 364 at the 13th ICHPS in 2020,
reflecting increased demand for this unique conference that catalyzes the development and
dissemination of innovative health services and health quality research methods and tools.
As with previous ICHPS conferences supported by the Agency for Healthcare Research
and Quality (AHRQ), the technical program for the 14th ICHPS will examine topics that fit
perfectly with AHRQ’s goals. The invited and contributed presentations and posters promote
improvements in the quality, safety, efficiency, and effectiveness of health care by developing,
debating and disseminating state-of-the-art research methods. Workshops, which follow a short
course/tutorial format, provide conference attendees with the theory and skills to incorporate the
latest methods into their research and practice.
As with past ICHPS conferences, we plan to disseminate conference papers through a
special issue of Springer’s journal, Health Services and Outcomes Research Methodology. The
ICHPS 2020 issue: https://link.springer.com/journal/10742/volumes-and-issues/21-1. During the
conference we plan to video record the two keynote speakers’ presentations and selected
workshops and post them to the ASA website (with speaker permission). We will also publish
articles on emerging topics and themes and interviews with award winners in newsletters and
social media so that the conference developments reach a wider audience.

Public health relevance
The 14th International Conference on Health Policy Statistics (ICHPS) 2023, hosted by the American Statistical Association (ASA) and its Section on Health Policy Statistics (HPSS), will provide a unique forum for the dissemination of statistical methods and data science tools relevant to contemporary health services and outcomes research. ICHPS 2023 will engage a host of stakeholders and bring a variety of perspectives and novel approaches to salient health policy issues. The timely theme of ICHPS 2023 is “Upgrading the Pipeline from Health Data to Health Policy,” shining a spotlight on the interconnected nature of health data and quantitative methods in informing health and policy decision-making.